DYNAMICS OF IONIC MESSENGERS IN NEURONS

This proposal aims to develop and exploit new optical methods for probing the intracellular ionic signals resulting from neuronal activation and signaling. The initial focus is on Ca2+ and Na+, which are of enormous importance in neuronal electrophysiology, exocytosis, nutritive homeostasis, growth, and plasticity. Molecular designs and synthetic routes are proposed for 1) fluorescent Ca2+ indicator dyes with visible excitation wavelengths and a shift in emission wavelengths upon binding Ca2+ for use in scanning confocal microscopy of living neuronal assemblies; 2) dyes that are triggered by a light flash to memorize the instantaneous Ca2t concentration in the form of an irreversible photochemical isomerization whose extent can be assessed after tissue sectioning; 3) Ca2+-specific, photolabile chelators in which light increases or decreases their affinity by a larger factor than presently available; 4) reversible photolabile Ca2+ chelators which can be repeatedly cycled between low and high affinity states; and 5) Na+ indicators with better optical responsiveness and K+ rejection than currently available. Both presently existing probes and their projected siblings would be exploited in a wide variety of neuronal preparations. For example, with an emission-shifting Ca2+ indicator and a ratiometric, video-rate-scanning confocal microscope, it should be possible to quantify the diffusion gradients of Ca2+ spreading from active membranes of isolated neurons and to visualize dynamically the receptive fields and signal propagation in sensory ganglia and tissue slices of significant thickness. Flash-triggered Ca2+-memorizing dyes would give even higher spatial resolution, ultimately down to the electron-microscopic level using immunocytochemistry, at the expense of continuous recording over time. Photochemical release or uptake of Ca2+ would permit calibration of the Ca2+ sensitivity of channels, exocytotic mechanisms, synaptic modulation, and neurite growth, or in general the extent to which Ca2+ is necessary or sufficient for cell function such as transmitter release or long-term potentiation. A photo-reversible chelator would be even more versatile, permitting generation of prolonged artificial trains or spatial gradients of Ca2+ by alternating two wavelengths in time or shining them on adjacent spatial regions. Na+ indicators should be used to examine how well neurons regulate cytosolic Na+ after bursts of action potentials, how effective Na+Ca+ exchange is, and what role Na+ accumulation may play in mediating post-tetanic potentiation and longer-term trophic effects.